ATTENTION &INFORMATION PROCESSING IN CHILDREN WITH MILD TO MODERATE HEAD INJURY

This controlled study will explore the nature of attention and information processing deficits associated with mild to moderate head injury in children. We plan to follow a group of head-injured children over a 6 month period to evaluate the level of recovery, or possible deterioration, of cognitive processes. In addition to a battery of standardized neurophychological tests, we will include an experimental investigation of attentional proccesses under varying distractor conditions.